Michigan Otolaryngology Research Education (MORE)

Abstract
Physician-scientists play key roles in discoveries and the ensuing translation of research advances into improved
health care for patients, a process central to the NIH Roadmap. Therefore, dedicated and intensive research
education is essential to developing the next generation of clinician-scientists. Otolaryngologists are trained and
primed to undertake research in the NIDCD mission areas of hearing, balance, voice, communication disorders,
taste, smell, and related cellular biology. The goal of this training grant is to provide research experiences at key
stages of medical training. Specifically, we propose to support: 1) 9-month predoctoral research experience for
two medical students interested in otolaryngology and the communication sciences, to encourage pursuit of
residencies that include research training and, ultimately, academic careers; and 2) 18 months of research
education for otolaryngology residents to define and develop a research interest to be continued as an academic
faculty member. Preceptors have been selected from the internationally-recognized faculty at the University of
Michigan, consisting of basic science, translational and clinical researchers with primary appointments in the
departments of Otolaryngology-Head & Neck Surgery, Neurology, Psychiatry, Psychology, Anesthesiology,
Family Medicine, Internal Medicine, Pediatrics, Human Genetics and Mechanical Engineering. Major focuses of
research include the mechanisms of hearing loss and hearing restoration, head and neck oncology, tissue
bioengineering, nerve regeneration, 3D printing, applied cochlear implant research and health services for deaf
and hard of hearing patients. Each trainee will have academic otolaryngology faculty as either a primary or a
secondary mentor. Emphasis will be placed on project design/translational potential, multidisciplinary
collaboration, grantsmanship, manuscript development, and presentation of research proposals and findings.
Opportunities will be provided to attend extramural or intramural conferences or educational courses relevant to
the trainee's chosen research discipline. The program benefits from the well-equipped facilities of the
Department of Otolaryngology-Head and Neck Surgery and the Kresge Hearing Research Institute as well as
our broader university infrastructure. The Michigan Institute for Clinical and Health Research (MICHR), funded
by a Clinical Translational Science Award, also provides outstanding training opportunities as well as resources
in clinical research methodology. In addition, the University of Michigan has extensive investments in both clinical
and basic research in terms of numerous core facilities, and major cross-departmental centers.

Public health relevance
Project Narrative The goal of the MORE program is to provide research training fellowships to medical students and otolaryngology residents in the NIDCD mission areas of hearing, voice, communication disorders, taste, smell, balance, and head and neck oncology. The long term goal is to develop the next generation of clinician-scientists in otolaryngology, who can both treat patients with these disorders as well as advance the science in ways to improve the health and well-being of future generations of patients.